Mississippi Perinatal COVID-19 Registry

Perinatal COVID-19 Databank Project Summary The COVID-19 pandemic affected mostly adult population over 60 years of age during the first months of its inception around the world. However, due to the rapid spread of the virus in the community children and pregnant women were affected within the first year of the pandemic. The effect of COVID-19 in children was reported in over two thousand articles since the beginning of the pandemic. The majority of these articles focused on the clinical feature of acute COVID-19 onset in the pediatric population. Moreover, reports of COVID-19 cases in children are growing steadily since March 2020 according to the CDC’s Morbidity and Mortality Weekly Report on 6/ 2021. The perinatal exposure to SARS CoV-2 in infants from mothers diagnosed with COVID-19 is a topic characterized by controversy and lack of clear understanding on the etiology of the condition, and the short and long term consequences. Therefore, the best approach to understand the etiology, management and consequences of COVID-19 is to study its natural progression. Birth cohort studies provide critical information for the investigation of the origins, and natural progression of diseases. This project proposes the development of a shareable compendium of perinatal COVID-19 cases from the State of Mississippi. The Patient Cohort Explorer and COVID-19 Research Registry databases developed at the University of Mississippi Medical Center will serve as the foundation to build a compendium of perinatal COVID-19 cases including mother/infant dyads. This database will capture clinical and demographic information from mother and newborns infant affected by COVID-19, and receiving medical care in the University of Mississippi Medical Center, which is the only referral center for maternal fetal healthcare in the State. In addition, the database will include information from satellite clinics associated with the Medical Center, and COVID-19 data from public health datasets from the Mississippi State Department of Health. This database will provide shareable de-identified patient information with query, pairing and follow-ups capabilities on medical conditions, diagnosis, management, treatment and outcomes. In addition, this project will incorporate and link data from the University of Mississippi Medical Center biobank management system and the geographic information system providing access to biological samples and geolocation of COVID-19 cases.

Public health relevance
The COVID-19 pandemic is currently affecting individuals from all ages, including pregnant women and newborns. The perinatal exposure to SARS CoV-2 in infants from mothers diagnosed with COVID-19 is a topic characterized by controversy and lack of clear understanding on the etiology of the condition. This project will help to provide medical, biological, and geolocation information of perinatal COVID-19 cases, to improve the understanding of this condition.